American Society of Biomechanics Annual Meeting

PROJECT SUMMARY/ABSTRACT
The American Society of Biomechanics (ASB) is the foremost society for biomechanics research and
engagement in the United States. The Society’s annual meeting brings together an interdisciplinary group of
researchers interested in the application of mechanical principles to biological problems, both basic and
applied. The research portfolio of ASB’s membership is highly interdisciplinary and complements the missions
of the National Institute of Child Health and Human Development (NICHD) Center for Medical Rehabilitation
Research (NCMRR) and National Institute Arthritis and Musculoskeletal and Skin diseases (NIAMS) by
fostering discovery and dissemination of scientific knowledge through basic, translational, and clinical research
that aims to enhance the health, productivity, independence, and quality of life of people with physical
disabilities or musculoskeletal diseases.
The 2023 annual meeting of the ASB, which will be held in Knoxville, TN, is being hosted by faculty at the
University of Tennessee, Knoxville. The meeting will feature a variety of activities designed to foster a lively
interchange of ideas, including podium presentations, thematic poster sessions, invited symposia, keynote
lectures, poster presentations, topical tutorials, laboratory tours and a variety of mentoring and diversity events.
Student participation and mentoring are priorities for the Society. Meeting attendance is anticipated to exceed
800 delegates, of which nearly half are expected to be students. Mechanisms have been established to
specifically encourage and support the participation of women, underrepresented minorities, and persons with
disabilities.
Along these lines, under the direction of the current Diversity Chair, Ajit Chaudhari, PhD, the Society will
continue to administer a Diversity Travel Award program, and organize three key events designed to (i.)
provide mentorship on professional development strategies to mid-career scientists in the Society (Mentoring
Lunch) (ii.) convene the women in the Society and offer strategies for negotiation across all career stages
(Women in Science), (iii.) bring together members of the Society to discuss systematic bias in the academy
with a focus on gender and gender identity (Diversity and Inclusion Lunch), and (iv.) engage educators and
students, including current Travel Awardees from diverse backgrounds, during and after the meeting (STEM
Education Program)..
This grant application seeks funding to continue supporting Diversity Travel Awards for ~24 attendees of the
meeting as well as a prominent keynote speaker for the STEM Educational Program. Travel awards have now
been offered at each of the last five in-person meetings (2015-19) of the ASB to individuals with disabilities and
from underrepresented backgrounds. These awards have proven to be successful in increasing diversity
amongst young active members who over time will become the future leaders of the Society and the field.

Public health relevance
PROJECT NARRATIVE The 47th annual meeting of the American Society of Biomechanics (ASB) will be hosted by faculty of the University of Tennessee, Knoxville at the Knoxville Convention Center in Knoxville, Tennessee, from August 8- 11, 2023. This proposal seeks funding to continue the Diversity Travel Award program targeted to increase the attendance of students, trainees, and junior faculty from underrepresented groups with a focus on engaging women, minorities, and persons with disabilities. This program will provide opportunities for networking and the exchange of ideas around research themes intended to enhance the health, productivity, independence, and quality of life of people with physical disabilities and musculoskeletal disease – encapsulating the mission of the NICHD-NCMRR and NIAMS.